Translational Control: Discovery and Mechanisms

Project Summary/Abstract
Ribosomes are at the center of gene expression regulation. Not only do they synthesize
proteins, but they regulate transcription and respond to stress signals. The translational control
underlies the pathogenesis of infectious and genetic diseases. Translation is a key antibiotic
target, but the emergence of antibiotic resistance poses a serious challenge in the fight against
infectious diseases. To improve our understanding of the translational control of gene
expression in molecular detail, we propose to elucidate the structural mechanisms of (1)
translation initiation of viral mRNAs and virus-like cellular mRNAs; (2) bacterial stress responses
which couple translation with transcription, conferring bacterial pathogenicity and antibiotic
resistance and (3) translation elongation and termination. Understanding these mechanisms
may enable discovery of novel drugs for the treatment of viral or bacterial infections or genetic
diseases caused by nonsense mutations.

Public health relevance
Project Narrative Ribosomes are at the center of gene expression regulation in all organisms. We will elucidate structural mechanisms of translation regulation during viral or bacterial infection, as well as genetic diseases. Understanding these mechanisms may enable discovery of novel drugs for the treatment of infectious diseases or genetic diseases caused by stop-codon mutations.